Development of a Values-Affirmation Intervention Targeting Medication Adherence in Older Adults with Heart Failure Completing Cardiac Rehabilitation

PROJECT SUMMARY/ABSTRACT
Aging adults, particularly those managing a chronic illness, face numerous challenges navigating changing
roles and functional abilities. Heart failure (HF) is prevalent among older adults and requires complex, long-
term disease management. Rehospitalizations are common, and often result from inadequate medication ad-
herence. Encouraging a connection between medication-taking and an individual’s core values may reframe
medication use as a self-guided effort to engage in personally meaningful living. Values-affirmation (e.g.,
inviting patients to reflect on important core values) can promote openness to health behavior change, and
may be a powerful motivational tool to enhance education and behavior skills adherence interventions. This
application proposes to develop a novel values-affirmation intervention to improve medication adherence in HF
patients enrolled in cardiac rehabilitation. The proposed Mentored Patient-Oriented Research Career Develop-
ment Award (K23) will provide Dr. Emily Gathright critical training in the development and evaluation of
behavioral self-management interventions for older adults with HF. Training in (1) biopsychosocial as-
pects of aging, (2) use of qualitative methods to guide theory-driven intervention development, (3) randomized
controlled trial (RCT) design and execution, (4) RCT analysis, and (5) professional development will bridge
prior training in psychosocial and behavioral determinants of prognosis in HF to interventions that improve out-
comes for older adults with chronic illness. Dr. Gathright will benefit from the support of a robust mentorship
team with complementary strengths and extensive experience leading federally-funded research. Expert men-
torship will be provided by leading scientists in the fields of aging and cognition, preventive cardiology, biosta-
tistics and methodology, behavioral interventions, qualitative methods, and pharmacoepidemiology. The Cen-
ters for Behavioral and Preventive Medicine at The Miriam Hospital (a Center of Excellence at the Alpert Medi-
cal School of Brown University) and Alpert Medical School’s Department of Psychiatry and Human Behavior
offer an impressive training environment with a strong record of successful completion of K awards. Dr. Gath-
right will develop a values-affirmation medication adherence intervention through three aims: (1) Focus groups
(6-8; N = 30-48) will be conducted to identify core values most relevant to HF medication adherence, and to
guide the development of a combined values-affirmation and skills-building intervention; (2) Intervention feasi-
bility and acceptability will be evaluated and refined following a small, open trial (N = 12); and (3) Intervention
feasibility, acceptability, and preliminary efficacy will be examined using a pilot RCT (N = 50) comparing the
intervention to a no-treatment control group. The project will lay the foundation for a subsequent RCT to evalu-
ate efficacy and mechanisms of action. The K23 proposal provides clear and achievable training and research
plans that will move Dr. Gathright toward her goal of becoming an independent, clinical researcher developing
novel and innovative approaches to improve disease management for older adults with chronic illness.

Public health relevance
PROJECT NARRATIVE The proposed Mentored Patient-Oriented Research Career Development Award (K23) will provide critical training in biopsychosocial aspects of aging, clinical trial design and execution, and qualitative and quantitative methods to support intervention development toward the goal of becoming an independent, clinical researcher developing novel and innovative approaches to improve disease self-management for older adults with chronic illnesses. Heart failure is the leading hospital discharge diagnosis among older adults, and poor medication adherence undermines effective heart failure management and is associated with hospital readmission and lower survival rates. Thus, this application proposes structured training and mentored experience to aid in the development of a novel values-affirmation, education, and behavior skills-building intervention to improve medication adherence in heart failure patients enrolled in cardiac rehabilitation.